Tumor-cell intrinsic and extrinsic determinants of drug resistance and metastasis

PROJECT SUMMARY
Despite advances in cancer therapy, metastatic disease is overwhelmingly fatal and accounts for most cancer-
related deaths. Systemic therapies fail to control disseminated disease due to a mix of innate and acquired
resistance. The processes that drive drug resistance and metastasis are a combination of tumor cell-intrinsic
mechanisms, such as genetic and epigenetic changes, and extrinsic factors, including the tumor immune
microenvironment (TIME). I propose a comprehensive research and training plan to investigate both dimensions.
F99 Phase: My doctoral work focuses on a cancer cell-intrinsic mechanism, the role of Claudin-1 (CLDN1)
expression in promoting chemoresistance and metastasis in colorectal cancer (CRC). My work thus far (Aim 1A)
details a novel mechanism in which CLDN1 interacts directly with the receptor tyrosine kinase Ephrin type-A
receptor 2 (EPHA2) in CRC and inhibits its degradation. The increase in protein-level EPHA2 enhances AKT
signaling and CD44 expression to promote cancer stemness and chemoresistance. Previous work has shown
that CLDN1 expression promotes CRC metastasis in mouse models. My future work (Aim 1B) will investigate
the molecular details of the CLDN1/EPHA2 interaction; compare patterns of CLDN1 and EPHA2 expression in
patient-matched normal, primary tumor, and metastatic tumor tissues; and look specifically at the role of the
CLDN1/EPHA2 interaction in promoting metastasis. Aim 1 will provide training in bioinformatics, organoid culture,
and orthotopic metastasis models. K00 Phase: In my postdoctoral phase, I will study the extrinsic factors
influencing breast cancer (BC) dormancy and metastasis in the liver. Cancer cells spread to distant organs early
in tumor development. These disseminated tumor cells (DTCs) can enter a state of dormancy and survive initial
therapy, only to reactivate years later, resulting in relapse. It is well-accepted that the factors regulating dormancy
and reactivation depend on the microenvironment of the host organ. Even though hepatic BC metastases carry
the worst prognosis, the factors regulating dormancy and reactivation in the liver are understudied, particularly
in a fully intact TIME. In Aim 2.1, I will use immunocompetent mouse models to study the role of T-cells in
regulating BC dormancy in the liver. Evidence suggests that hepatic stellate cell (HSC) activation may be a
critical factor in DTC reactivation. Activated HSCs are a hallmark of non-alcoholic fatty liver disease (NAFLD).
NAFLD is the most common liver disease in the world, but its impacts on BC metastasis are not well studied.
Aim 2.2 will use mouse models of NAFLD to study its effect on BC dormancy and metastasis. Aim 2.3 will use
innovative ex vivo whole tissue slice cultures to study the signaling networks regulating BC dormancy and
immune evasion. Aim 2 will provide training in cancer immunology, advanced cancer models that accurately
model the TIME, and analytical techniques capable of single-cell resolution. The proposed studies will offer
insights into the causes and therapeutic vulnerabilities of metastatic disease and will provide a multidimensional
training program that will prepare me for a career as an independent cancer researcher.

Public health relevance
PROJECT NARRATIVE Despite advances in cancer treatment, metastatic disease is almost always fatal. In addition, tumor cells can spread early to distant organs, survive initial treatment, and lie dormant for years before reactivating to produce a detectable tumor. This study will investigate the tumor cell-intrinsic and extrinsic factors that drive drug resistance and metastasis.